ALCOHOL POLICY INFORMATION SYSTEM

The Alcohol Policy Information System (APIS) provides detailed information on a wide variety of Alcohol-Related Policies in the United States at both State and Federal levels, as well as policy information regarding the Recreational Use of Cannabis. The information and resources available on this site are geared toward alcohol and cannabis policy researchers and others interested in alcohol and cannabis policy issues.